U6 RNA - U2 COMPLEX

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. NMR time is requested to investigate the structure of a U6 RNA binding protein, Prp24. This protein is 25 kDa and well folded as determined by 2D HSQC. We intend to solve the structure of Prp24, and have produced a 13C, 15N double labeled NMR sample for this purpose. Assignments will be obtained through an automated assignment procedure, PISTACHIO, recently developed by Eghbalnia et al.